Endocannabinoid Biosynthesis in Inflammation and Pain

Project Summary
In the initial 5 years of this grant, our group has advanced the field of endocannabinoid therapeutics by
discovering novel metabolic and signaling functions for the endocannabinoid biosynthetic enzyme DAGLβ in
inflammation and pain response. We developed drug delivery strategies for localizing DAGLβ inhibitors to
inflammatory sites for potent pain alleviation in preclinical models. We developed phosphoproteomic,
chemoproteomic, and lipidomic capabilities to enable biomarker and drug discovery in pain. This renewal
application will extend our preclinical investigations of DAGLβ inhibitors as non-opioid analgesics to include
kinase activation as a testable mechanism. We will build on the key biological discoveries, productivity, and
technological investment of the first funding period to address key gaps in knowledge to probe how disruption of
DAGLβ lipid metabolism activates kinase signal transduction, test whether augmented kinase activation can be
achieved using new liposomal formulations of DAGLβ inhibitors and uncover the druggable phosphoproteome
in inflammatory and neuropathic pain states. We plan to test our central hypothesis that DAGLβ signals through
bioenergetic pathways to alter the macrophage phosphoproteome in local inflammatory responses in pain. An
improved understanding of endocannabinoid biosynthetic mechanisms in chronic pain states is important for
guiding development of non-addictive, targeted analgesics to address the opioid epidemic.

Public health relevance
Project Narrative This application will investigate how disruption of endocannabinoid biosynthetic pathways alter the phosphoproteome in chronic pain states. The model system tested will identify lipid metabolism and phosphorylation events that reprogram immune and nociceptor signaling in pathogenic pain states. The molecular insights gained from the proposed studies will guide the development of non-addictive, targeted analgesics to reduce the prevalence of opioid addiction and dependence in patients with chronic pain.